EARLY PHASE CLINICAL TRIAL UNITS (EPCTU): PHASE I CLINICAL TRIAL TO EVALUATE A SARS-COV-2 THERAPEUTIC

The Early Phase Clinical Trial Units provide a vehicle for investigation of new agents in the treatment and prevention of infectious diseases, and can carry out all aspects of interventional clinical trial implementation.